Targeting Dystroglycanopathies using Pluripotent-derived Myogenic Progenitors

Summary
The biochemical hallmark of FKRP-associated dystroglycanopathies is the hypoglycosylation of α-dystroglycan
(α-DG), which leads to disruption in the interaction of α-DG with extracellular matrix proteins, ultimately leading
to muscle wasting. Recessive mutations in FKRP are associated with a heterogeneous spectrum of muscle
disorders, ranging from severe early-onset to mild late-onset limb-girdle muscular dystrophy (LGMD2I) to several
forms of congenital muscular dystrophy (MDC1C), including severe Walker-Warburg Syndrome. Respiratory
impairment due to loss of diaphragm function is a prominent complication of both LGMD2I and MDC1C. No
approved therapy currently exists for dystroglycanopathies. There has been tremendous excitement for the
therapeutic potential of reprogrammed induced pluripotent stem (iPS) cells in treating genetic diseases. The
premise of this project is that stem cell-based therapy consisting of human skeletal myogenic progenitors derived
from iPSCs will replenish diseased muscle with normal functional muscle fibers as well as muscle stem cells,
which have the potential to provide long-term therapeutic effect in dystroglycanopathies. We have developed
and extensively validated a method to generate engraftable skeletal myogenic progenitors from pluripotent stem
cells through conditional expression of Pax3 or Pax7. This approach results in highly efficient generation of
therapeutic myogenic progenitors, which when transplanted into dystrophic mice locally or systemically produce
large quantities of functional skeletal muscle tissue that incorporates normally into the host muscle. Importantly,
a fraction of transplanted cells remains mononuclear, and displays key features of skeletal muscle stem cells,
including satellite cell localization, response to re-injury, and contribution to muscle regeneration in secondary
transplantation assays. Therefore, our technology comprises a cell therapy to rebuild functional skeletal muscle,
robust to future damage, in hosts with muscular dystrophy. We have recently shown that mouse and human
PSC-derived myogenic progenitors contribute to significant myofiber and satellite cell repopulation in the
immunodeficient FKRPP448L-NSG mouse model that we generated. Of therapeutic relevance, we have evidence
of successful delivery of these myogenic progenitors directly into the diaphragm of FKRP mice. In addition, we
have developed a universal gene correction strategy for FKRP, applied this to patient-specific WWS and LGMD2I
iPSCs, and demonstrated in vitro and in vivo rescue of functional α-DG glycosylation. In this application, we
propose studies that are critical for the development of successful therapeutic approaches for
dystroglycanopathies, including understanding 1) the effect of the environment on the engraftment of
transplanted cells and 2) the long-term functionality and molecular characteristics of human gene edited WWS
and unaffected iPSC-derived myogenic progenitors, important for both autologous and allogeneic future
therapeutic applications, respectively.

Public health relevance
Narrative This proposal takes advantage of the ability of pluripotent stem cells (PSC) to uniquely produce differentiated somatic cell types in large quantities. We have developed methods, based on the conditional expression of Pax3 and Pax7, to induce the muscle program in early mesoderm, and thus derive muscle progenitors with great efficiency for regenerative medicine and disease modeling. Our investigations will focus on understanding the effect of the environment on the engraftment of PSC-derived myogenic progenitors, and the molecular signature and long-term regenerative potential of control and gene corrected FKRP mutant PSC-myogenic progenitors.